Equipment Supplement in support of GM/CA@APS Synchrotron

The purpose of this agreement is to provide equipment funds for a replacement of the focusing mirrors on beam line 23-ID-D at the APS Synchrotron at Argonne National Laboratory.